Evaluating environmental control (AVOID) and inhibitory control (RESIST) strategies to improve weight management outcomes

ABSTRACT
Evidence-based weight management programs are effective when individuals are able to consistently adhere to
recommendations. However, a large proportion of treatment-seeking individuals do not experience clinically
significant weight loss. Innovative strategies are needed to optimize behavior change in weight management
interventions. The proposed randomized controlled trial tests two self-regulatory approaches to improve
intentional weight loss and diet quality in individuals with overweight or obesity: (1) an environmental control
strategy (AVOID) and (2) an impulse control training strategy (RESIST). Specifically, 500 women and men (BMI
between 25-39.9 kg/m2) will be recruited from the Cedars-Sinai Medical Center network of hospitals and clinics.
All participants will be enrolled in a 12-month weight-management program (WW, formerly Weight Watchers©)
focusing on diet, physical activity and mindset skills, and randomized to one of four study arms: (1) WW only, (2)
WW + modification of home food environment and online grocery delivery (AVOID), (3) WW + gamified inhibitory
control training (RESIST), (4) WW + AVOID + RESIST. Baseline, 6- and 12-month assessments will be
completed by experienced, English and Spanish speaking study staff. Aim 1 (Outcomes). (a) Tests how AVOID
and RESIST affect weight loss and waist circumference (primary) and diet quality (secondary). H1a: AVOID
and/or RESIST (arms 2, 3, 4) will result in greater weight loss at 6-month and 12-month timepoints compared to
WW alone. (b) Tests potential ripple effects of AVOID and RESIST on available household members' diet quality
(primary) and weight (secondary). H1b: We predict that AVOID (arms 2 and 4) will produce greater dietary
changes in household members than WW alone and RESIST (arms 1 and 3). Aim 2 (Mechanisms). Tests the
mechanistic pathways of AVOID and RESIST by (a) comparing longitudinal changes in inhibitory control and
home food environment across study arms; and (b) whether inhibitory control and the home food environment
mediate the relationships between study arms and anthropometric and dietary outcomes. H2: AVOID will
produce changes in the home food environment and RESIST will operate on inhibitory control. Aim 3
(Moderators). Examines how (a) individual characteristics (age, sex, ethnicity, socioeconomic status, household
composition, physical activity, baseline BMI and executive functioning), and (b) process data (frequency of
grocery delivery, dining out and take out, impulse control training and WW app use) moderate the relationship
between study arms and anthropometric and dietary outcomes. These considerations are important to help
explain heterogeneity in intervention outcomes and to understand who benefits from AVOID and/or RESIST.

Public health relevance
NARRATIVE The proposed prospective, four-parallel-arm, randomized controlled trial tests two theoretically driven strategies to improve weight and dietary outcomes in women and men with overweight or obesity who are attempting to lose weight: an environmental control strategy and an impulse control training strategy. This research addresses the oft-debated question of how to best optimize behavior change, and whether one should attempt to resist temptation in consistently inhibiting impulses or avoid temptation altogether in eliminating unhealthy options from the home environment.